Involution-based biomarkers of breast cancer risk

PROJECT SUMMARY/ABSTRACT
The breast lobules are the structures that produce milk in lactating women, and are also the primary
site of origin for breast cancer. Age-related lobular involution (LI) is a physiological process in which the
epithelial tissue of the breast lobules gradually regresses with age, corresponding with elimination of the need
for milk production beyond the child-bearing years. Analysis of our cohort of more than 14,000 women with
benign breast disease (BBD) revealed that LI is strongly associated with reduced risk of subsequent breast
cancer, and thus LI constitutes a natural mechanism for prevention of breast cancer. However, more than 40%
of postmenopausal women with BBD have not completed LI, and these women are at substantially greater risk
of developing breast cancer compared to women of similar age whose involution process has completed. In
this application, we propose experiments to identify critical effectors of LI and to determine how these can be
used to improve breast cancer risk assessment for women who have not undergone LI. In Aim 1, we will define
the mediators that underlie the link between delayed LI and a high risk cellular phenotype. We will use a newly-
generated panel of very early passage primary human mammary epithelial cells (HMECs) derived from women
with BBD and varying degrees of LI, in combination with humanized mouse xenograft models in which the LI
status of the HMECs is manifest. In Aim 2, we will identify mediators associated with ongoing vs delayed LI in a
newly-defined clinical cohort of peri- and post-menopausal women for whom multiple, sequential benign
biopsies are available. In Aim 3, biomarkers discovered in Aims 1 and 2 (plus other promising biomarkers) will
be evaluated for association with subsequent breast cancer in a patient cohort of postmenopausal women.
The cohorts interrogated in Aims 2 and 3 will be drawn both from the Mayo Clinic BBD cohort, which is
primarily composed of White/Caucasian women, and the Detroit BBD cohort, which is composed of
Black/African-American women, which will allow us to evaluate race as a biological variable in our analyses. By
providing insight into the processes that control LI and by developing tractable experimental models in which to
evaluate the effects of modulating those processes, our work will provide a better understanding of LI delay
and its link to breast cancer and will point toward methods for inducing LI in women for whom this process is
stalled or delayed, as a physiologically-derived method for breast cancer prevention.

Public health relevance
PROJECT NARRATIVE By analyzing tissue samples from benign breast biopsies, we have found that more than 40% of postmenopausal women have incomplete lobular involution, and that these women are at substantially greater risk for subsequently developing cancer. Our project will provide insight into the previously unstudied mechanisms that control lobular involution and will define why postmenopausal women who have not completed the process of lobular involution are at greater risk for breast cancer development. This research will be crucial for better guiding women who obtain breast biopsies toward the most appropriate strategies of surveillance, risk management, and treatment, and will also point towards new physiologic strategies to reduce breast cancer incidence, including the induction of lobular involution in postmenopausal women for whom this process is incomplete.